Does lead (Pb) poisoning impair brain development by affecting how thyroid hormone gets into the brain?

Project Summary
Lead (Pb) poisoning is a persistent health issue in the United States due to legacy contamination from
Pb-based sources such as paint, plumbing, and gasoline. Children are most susceptible to Pb
poisoning, which causes persistent cognitive deficits and low IQ. The specific mechanisms by which Pb
poisoning impacts development are not fully understood, however. Previous research showed that Pb
impacts several thyroid hormone (TH)-related processes, including decreases in expression of TH
distributor proteins (THDPs) in the choroid plexus. This is an important issue because TH is a critical
regulator of brain development; disrupted TH signaling in utero leads to smaller brain size and mental
retardation. The impact of Pb-induced THDP impairment on development has not been fully tested.
Given the impact of Pb on THDP expression, our central hypothesis is that Pb poisoning impairs TH
distribution into the brain and compromises TH-dependent developmental mechanisms. TH regulates
important aspects of brain development in both humans and amphibian, in some surprisingly similar
ways. The overall rationale of this proposal is that TH is the key driver of metamorphosis in frogs, which
makes tadpoles ideally suited to address how Pb dysregulates TH-dependent mechanisms of
development. We will use Xenopus laevis tadpoles to assess the impact of Pb on the expression and
function of THDPs in the choroid plexus and its effects on TH-sensitive cellular and molecular
mechanisms brain development. The central hypothesis will be tested in three specific aims: 1) To
determine the effects of Pb poisoning on expression of THDPs, TH-sensitive genes, neurogenesis,
neuronal differentiation, and spine maturation using time-lapse in vivo imaging techniques. 2) To test if
knockdown of THDP expression in the choroid plexus mimics the effects of Pb poisoning. 3) To test if
overexpression of THDPs in the choroid plexus can counter the effects of Pb-poisoning on TH-
dependent mechanisms of brain development. The outcomes of this research will test a significantly
understudied mechanism by which Pb is hypothesized to compromise development. These protocols
will serve as a new, unique set of sensitive end points to evaluate not just heavy metals but any chemical
suspected of disrupting THDP expression and function. This proposal is innovative because it uses
advanced techniques that have not been previously used in animals to address the issue of
developmental Pb neurotoxicity. This project is significant because it will conclusively test the degree
to which Pb affects development via dysregulation of TH-signaling and therefore may lead to
alternative/complimentary therapies for counteracting Pb-poisoning in children.

Public health relevance
Project Narrative The proposed research is relevant to public health because the experiments will assess previously unconsidered mechanisms by which lead poisoning impairs development, including brain development. This project is relevant to the portion of NIH’s mission to engage in fundamental scientific discovery and develop innovative research strategies in order to protect health.